Kentucky Center for Clinical and Translational Science

Contact PD/PI: Kern, Philip A.
PROJECT SUMMARY – OVERALL
The University of Kentucky (UK) Center for Clinical and Translational Science (CCTS) has created an
integrated home for clinical and translational research which promotes scientific progress and discoveries at
every phase of the translational continuum. The CCTS has partnered with communities in Central Appalachia
to address multiple generations of recalcitrant health inequities related in part to the economic distress of rural
communities. The CCTS has fundamentally transformed UK and Central Appalachia through the development
of strong academic-community research networks and collaborations within the CTSA consortium.
Appalachian health disparities are further magnified by the opioid and substance abuse epidemic, which has
greatly impacted eastern Kentucky and West Virginia. The strong UK research portfolio puts the UK CCTS in
an optimal position to lead local, regional and national research efforts focused on rural health inequities.
The aligned missions of UK, UK HealthCare and the CCTS focus on achieving health equity by engaging in
highly innovative, collaborative and dynamic translational research to address rural health needs. The CCTS
will continue to educate the translational workforce of the future, engage rural communities in translational and
bi-directional team science and work with the national network to advance transdisciplinary research and
clinical trials through the following Specific Aims: 1) develop, innovate and transform our research environment
to promote impactful science and discovery within our integrated health care system to meet the unique health
needs of Central Appalachian residents; 2) lead institutional innovation in the delivery of impactful clinical and
translational research that covers the lifespan, fully engages the community and embraces team science; 3)
catalyze an efficient, university-wide clinical trials organization which adds value to the CTSA consortium by
engaging participants from rural Central Appalachia; and 4) foster and enhance a workforce characterized by
diversity and inclusivity across all translational science disciplines and populations. The UK CTSA hub is
uniquely positioned in the National CTSA Consortium to foster novel technologies, team science, clinical trial
start-up and cutting-edge translational research across the lifespan with a focus on rural communities. We
have a particular focus on the Central Appalachian community, a rural area with many of the highest levels of
health disparities in the nation. This focus will ultimately elevate the health and quality of life of rural
communities throughout the United States.
Project Summary/Abstract Page 276
Contact PD/PI: Kern, Philip A.

Public health relevance
PROJECT NARRATIVE – OVERALL The UK CTSA program hub is uniquely positioned in the National CTSA Consortium to foster novel technologies, team science, clinical trial start-up and cutting-edge translational research across the lifespan. Our UK CTSA hub has a significant presence on the national stage, and our focus on the Central Appalachian community, a rural region with many of the highest priorities (i.e., cardiovascular, neuroscience, cancer, obesity/diabetes) of health disparities in the nation and an epicenter for the opioid and substance abuse epidemic, distinguishes our mission and activities. The programs in this proposal will ultimately elevate the health and quality of life for people of this region and provide a national model for rural, underserved populations. Project Narrative Page 277